Hippocampal Shape Recovery & Analysis in Epileptics

DESCRIPTION (provided by applicant): This project aims to automatically recover and analyze the 3D hippocampal shape from human brain MRI and localize the epileptic focus to the appropriate temporal lobe. The hypothesis is that shape differences (not volume) between the left and right hippocampi will distinguish patients with epilepsy from healthy controls and identify the hemispheric location of the epileptic focus. We propose a three phase solution to test this hypothesis: (a) the development of a learning algorithm to create hippocampal shape and image atlases for use in segmentation, (b) automatic (atlas-based) hippocampal segmentation and validation, and (c) automatic classification of patient scans and validation of the classifier. The proposed new segmentation scheme will involve an atlas-based approach wherein the atlas is constructed from a prospective data set using a novel learning algorithm based on finding the atlas shape as the minimum distance fitted shape from the given population of fitted shapes. An MR image atlas learned similarly will be used to augment the learned shape prior. The learnt atlases will then be employed for estimating the non-rigid deformation field required to achieve an atlas-based segmentation of the unknown subject scan from an archive of retrospective data. A novel classifier based on the Kernel Fischer discriminant is proposed for automatically classifying subjects into groups corresponding to controls and those with epileptic foci localized to either the left or the right lobe. The segmentation and the classification algorithms will be validated on synthetic and real MR brain scans from an archive. The proposed algorithmic schemes have considerable potential for use in the segmentation and analysis of other anatomical structures and thus have utility for other disease states.